Post-traumatic vulnerability to cerebral ischemia

Project Summary
Traumatic brain injury (TBI) has recently been identified as an independent risk
factor for ischemic and hemorrhagic stroke. A history of TBI confers enhanced risk of
stroke incidence at a rate similar to other traditional stroke risk factors including smoking
and hypertension. In addition, TBI survivors who subsequently have a stroke have
increased likelihood of mortality, suggesting that TBI renders brain tissue more vulnerable
to ischemic damage. Here we present data generated in mice demonstrating that mild
closed head traumatic brain injuries transiently, but significantly, limit central glucose
utilization, impair insulin receptor sensitivity and reduce mitochondrial energy production.
Furthermore, when ischemic stroke (induced via middle cerebral artery occlusion) occurs
one week after TBI, the inflammatory responses, infarct size and functional deficits are all
markedly worse than in mice without a history of TBI. Treating metabolic dysfunction
pharmacologically attenuated TBI-induced exacerbation of ischemic outcome. The
overarching hypothesis of this application is that TBI-induced metabolic dysfunction
renders the brain less able to utilize metabolic fuels, and in turn more vulnerable to
ischemic damage. The three specific aims will (1) compare the effects of TBI history on
stroke-induced CNS inflammation, metabolic physiology, and neuronal death in male and
female mice and determine the time course of vulnerability after injury (2) determine
whether normalizing insulin signaling during the first several days after prevents the
exacerbation of stroke damage and improves mitochondrial respiration and (3) take steps
to gain independent funding. Together, these studies will raise awareness of the elevated
stroke risk among TBI patients, and by determining the underlying physiological
mechanism may offer new directions for TBI treatment that will minimize stroke risk and
improve outcomes for individuals who have suffered a TBI.